Somatic Mutations in Neurodevelopment and Disease

PROJECT SUMMARY
Somatic post-zygotic mutations are increasingly recognized as a cause of neurologic disorders ranging from
epilepsy to autism to neurodegeneration. Somatic mutations accumulate with each cell division during fetal life,
a developmental process of not yet fully defined scale and mechanism, hampering interpretation of disease
states. The first part of this study implements a clinically applicable somatic-aware algorithm to identify early
somatic mutations that lead to epilepsy and brain malformations. The latter aspect applies cutting-edge single-
cell DNA technology to human fetal brain in order to define the rates and mechanisms driving accumulation of
somatic mutations in neurons during normal development. The insights from this study have the potential to
impact the detection and diagnosis of somatic disorders in clinical practice, and defines the scope of normal
brain developmental mosaicism in neurons to serve as a framework for future studies of neurological disease.
The candidate’s career goal is to become an independent physician-scientist contributing to the
understanding of genetic and functional implications of post-zygotic mutations in childhood neurological
disorders. The candidate trained clinically in child neurogenetics with deep research experience, including in
cellular and molecular biology and statistical analysis, acquired in the cancer field. During the mentored training
period, the candidate will prioritize activities to transition skills from a cancer background to human genetics and
neuroscience: specifically working with primary human postmortem tissue, single cell analytical methods, and
evaluating genotype-phenotype relationships in somatic disorders, and additionally, preparing for a transition to
independence. The candidate will be mentored by Dr. Christopher Walsh, a renowned neurobiologist who has
mentored dozens of successful independent investigators and will be supported by an advisory team with
expertise in epilepsy, neuroscience, and bioinformatics. The proposed research and training plan will take place
in the laboratory of Dr. Walsh at Boston Children’s Hospital (BCH), which is affiliated with Harvard Medical School
and Howard Hughes Medical Institute, embedded within a world-class life sciences community of the Boston-
Cambridge area. The candidate will benefit from both the outstanding resources and intellectual community of
this tremendous network in addition to the close-knit communities within the BCH Department of Neurology and
Division of Genetics.

Public health relevance
PROJECT NARRATIVE Somatic mutations, those that exists in a subset of cells in the body, impact numerous neurologic disorders. However, because of the difficulty in identifying rare mutations accurately, we do not know the extent to which somatic mutations affect the brain. This proposal applies innovative technology to find somatic mutations that cause epilepsy and brain malformations and makes estimates of the degree to which normal brain development is impacted by somatic mutations.